Preclinical Translation of Kidney, Heart, and Lung Xenotransplantation

ABSTRACT
To earn the confidence of the scientific community, regulatory authorities, and, ultimately, our patients that
xenotransplantation deserves to be systematically evaluated in humans, it is essential to demonstrate consistent
long-term, life-supporting xenograft survival in a preclinical model. Although we have accomplished over one
year of life-supporting survival in nonhuman primates (NHPs) using kidney xenografts with knockout (KO) of
genes encoding three major carbohydrate xenoantigens (GalT, b4GalNT2 and CMAH KO, triple knock-out, TKO)
and multiple additional human transgenes, thrombotic microangiopathy (TMA) and antibody-mediated rejection
(AMR) remain the primary, prevalent causes of the TKO-based multi-gene edited (multi-GE) kidney and also
heart and lung xenograft loss. We will test four working hypotheses regarding the reason for these preclinical
and, in the case of heart xenografts, clinical failures. First, strong evidence implicates that knocking out the
CMAH gene in TKO (but not DKO) swine unveils the expression of a ‘4th antigen’ that is the target of innate
immunity in NHP but is irrelevant in human recipients. We will evaluate the contribution of the CMAH gene KO
to pathogenic immune injury occurring in TKO organ xenografts by comparing the performance, histology, and
molecular profile of kidneys, hearts, and lungs from 10-GE TKO to those from 9-GE DKO pig. We expect results
using DKO-based 9-GE pig organs will enable the design of IND-qualifying organ xenograft trials for one or more
organs. Second, based on compelling in vitro, ex vivo, and in vivo evidence that NK cells contribute significantly
to heart, kidney, and lung xenograft injury, we will test the hypothesis that activation of NK cells will be inhibited
by HLA-E expression on pig endothelium, which will attenuate inflammation and injury both in the xenograft and
systemically in the recipient. Third, we will optimize the immunosuppressive regimen for kidney, heart, and lung
xenografts. Finally, we will evaluate complement inhibition, CD11b blockade, donor macrophage depletion, and
ischemia minimization as strategies tailored to each organ with the general objective of effectively modulating
inflammation in the graft and organ xenograft recipient. The hypotheses, aims, and experimental approaches
are harmonized between each Project and supported by Administrative, Pathology Mechanistic, Infectious
Disease, and Swine Production Cores, which together will facilitate a coordinated effort to understand and
overcome the remaining barriers to the clinical application of kidney heart, and lung xenografts. To our
knowledge, MGH is the only center in the world capable of performing comprehensive comparative studies of
kidney, heart, and lung xenotransplantation in preclinical models. We anticipate that together, these highly
interactive projects will generate one or more safe and effective protocols ready for clinical trial by the end of the
funding period. If successful, these studies would impact the entire field of transplantation.

Public health relevance
PROJECT NARRATIVE Many patients with end-stage organ failure waiting for a transplant die each day because of the lack of donor organs. If pig organs could be used to increase the number of transplants every year, many lives would be saved. These studies will explore ways to achieve successful pig-to-human organ transplantation.